GENETIC HETEROGENEITY AMONG HUMAN SOMATIC CELLS AND ITS ACCUMULATION WITH AGE

ABSTRACT/PROJECT SUMMARY
From a human health perspective, genetic heterogeneity due to accumulation of mutations in normal
tissues increases cancer risk, and is likely an important factor in many degenerative diseases, such as
adult macular degeneration, congestive heart failure, inflammatory & autoimmune disorders,
sarcopenia & muscle weakness, and skeletal & joint degeneration. Somatic mutations can occur due to
DNA damage or replication errors. However, it has been difficult to detect somatic mutations in
individual patients because it has not been possible to reliably compare sequences of the genomes of
single cells. Human colon crypts can be used as a clonal representation of the colon stem cell at the
base of each crypt. Using SNP microarray, we have shown that large-scale human somatic cell-to-cell
differences (deletions, gene conversions, duplications) exist in colon crypts and increase with age. We
have optimized methods for whole genome sequencing without whole genome amplification to >30X
depth using a single colon crypt of 1000 to 2000 cells to study mutations accumulated in both nuclear
and mitochondrial genomes. An increase in single base mutations in both the nuclear and mitochondrial
genomes with age was observed in the whole genome sequencing analysis. Based on power
calculations using these preliminary findings, we propose to expand the study to include a total of 21
individuals distributed among three age groups to statistically validate our findings and examine
potential mechanisms for the age-related DNA damage. In Aim 1, whole sequencing libraries will be
constructed from five single colon crypts and the bulk tissue for >30X coverage of the genome from
each individual human subject over a range of ages from children to elderly. In Aim 2, the whole
genome sequencing data will be examined for point mutations and small indels, and for crypt to
germline and crypt-to-crypt changes in the same individual. In Aim 3, large deletions will be identified
to discern the mechanism of both the DNA breakage and the repair. In Aim 4, DNA sequence motifs at
sites of genetic change will be examined to identify preferred damage sites in the nuclear as well as the
mitochondrial genome. The potential biochemical basis and the molecular repair pathway of these age-
related DNA aberrations will also be explored. These efforts are important for understanding what DNA
sequences are at highest risk for the types of DNA damage or error-prone DNA repair that result in
accumulation of genetic change. This study will lay the foundation for future work to study how
environment and diet may affect the progression of somatic genetic changes over the human lifespan
as well as how polymorphisms may predispose some individuals to more rapid degenerative diseases
or cancer and thus permit consideration of preventive measures. Also, as diagnostic analysis relies
upon progressively fewer somatic cells, this knowledge of somatic cell genetic heterogeneity will
become increasingly important for precision medicine.

Public health relevance
PROJECT NARRATIVE Somatic cell genetic heterogeneity within an individual arises over the course of the human lifespan; but the quantitative extent and qualitative nature of this cell-to-cell change continues to be a matter of conjecture, because methods are limited. We recently developed a method to use single colon crypts as representative of one stem cell that would allow determination of the extent to which cells of the body diverge from each other genetically over the human lifespan. As analysis of the human body for medical and therapeutic reasons relies upon progressively fewer somatic cells, this knowledge of somatic cell genetic heterogeneity will become increasingly important.